U-RISE at University of North Florida

Project Summary/Abstract
The mission of the proposed Undergraduate Research Training Initiative for Student Enhancement (U-RISE)
program at University of North Florida (UNF) is to significantly increase the proportion of students from
underrepresented (UR) ethnic/racial minority or economically disadvantaged groups completing undergraduate
degrees and PhD or MD/PhD programs in biomedical sciences. We propose to develop this U-RISE program
across the UNF Biology, Chemistry, and Physics Departments; 44% of students from these programs are from
UR ethnic/racial minority or economically disadvantaged groups. The UNF Biomedical Sciences program bridges
these UNF departments with Mayo Clinic Florida, a major research-intensive academic medical center six miles
from UNF. This provides a strong foundation for the proposed program via established inter-institutional
initiatives that provide undergraduate research training. Pre-U-RISE scholars will be selected in spring of their
freshman year. With full financial support from UNF, scholars will begin the pre-U-RISE program in the summer
before sophomore year and gain critical experience in the responsible conduct of research as well as research
training at UNF or Mayo Clinic during their sophomore year to promote student retention. Pre-U-RISE scholars
will matriculate into the U-RISE program during the summer prior to junior year. As U-RISE scholars, students
will complete two summer internships, with at least one at a research intense institution (i.e. Mayo Clinic,
University of Central Florida, Florida State University). Scholars will also pursue academic year research at Mayo
Clinic or UNF, building their scientific identity and achieving full immersion in research. Through research,
scholars will develop myriad technical, operational, and professional skills. Other key aspects of the proposed
program include three-tier academic/research/peer mentoring, outreach, and professional development activities
that foster trainee independence, collaboration, and communication skills. These all represent evidence-based
interventions for increasing the persistence of students from UR groups in biomedical science. The proposed
program includes four major objectives: 1) Early identification and recruitment of students from UR groups
(minority/economically disadvantaged) and mentoring starting at end of freshman year; 2) a rigorous academic
preparedness program with continuous academic year research experiences at UNF or Mayo Clinic Florida; 3)
two summer research experiences; and, 4) a support system achieved through individualized mentoring,
advising, and continuous academic and financial support. Through these objectives, our U-RISE program aims
to yield outcomes that include increasing the 4-year graduation rate for scholars by >2-fold above current UNF
baselines and creating a diverse cohort of students that matriculate into graduate programs. This will ultimately
enhance the regional biomedical science training environment and increase workforce diversity.

Public health relevance
Project Narrative A diverse cross-disciplinary workforce highly trained in biomedical sciences is critical for addressing global health concerns. Training of students from underrepresented (UR) ethnic/racial minority and economically disadvantaged groups that matriculate into PhD or MD/PhD programs will help create a diverse biomedical sciences workforce for the Nation. This proposal aims to meet the unmet needs of diversity of the next generation of research scientists by enabling U-RISE trainees to achieve their potential.